MT-125 for the Therapeutic Treatment of Glioblastoma

PROJECT SUMMARY
An area of significant unmet need is the treatment of glioblastoma (GBM), an aggressive, fast-growing
and lethal brain cancer that represents 48% of all malignant brain tumors. Untreated, GBM is fatal within three
months, and due to its high rate of recurrence and invasive nature, the current standard of care, consisting of
safe maximal tumor resection, radiation therapy and chemotherapy, only extends survival following initial
diagnosis to one year. Invasion and proliferation, also known as Go and Grow, are defining phenotypes of GBM,
and GBM cells do only one or the other. However, blocking invasion stimulates proliferation and vice versa,
implying that an ideal therapeutic needs to block both Go and Grow simultaneously. Extensive genetic
interventions have shown that simultaneous disruption of two non-muscle myosin II (NMII) molecular motors
(NMIIA and IIB) meet these criteria. However, the translational potential of this research has been limited by the
lack of a clinically safe, CNS-penetrant NMII small molecule inhibitor. Following extensive medicinal chemistry
efforts to optimize selectivity for safety and tolerability, MT-125 was identified. MT-125 is a well-tolerated, dual
small molecule inhibitor of NMIIA and IIB with a high degree of brain penetrance, a requirement for an effective
GBM therapeutic. Preclinical in vitro and in vivo studies show that MT-125 blocks the Go and Grow phenotypes
and extends survival. Due to its unique mode of action, MT-125 also synergizes with existing FDA-approved
treatments, presenting a path to a potentially curative treatment. The overarching goal of the current proposal
is to ready MT-125 for rapid entry into IND-enabling studies. This will be achieved through several activities.
Phase I will focus on confirmation of preclinical efficacy with a clinically viable route of administration, in vitro
studies of synergy between MT-125 and additional existing FDA-approved treatments, and in vitro safety
profiling, pre-formulation studies and demo batch scale-up of MT-125. Quantitative milestones for transition to
Phase II are detailed in the application. In Phase II, in vivo efficacy testing will be performed on the most
promising synergy combinations identified in Phase I, as well as a non-GLP dosing safety study, GLP synthesis,
and formulations development with polymorph screening. The Commercialization Plan details the GBM market,
as well as Myosin Therapeutics’ clinical and regulatory strategy for rapid advancement of MT-125 to the clinic.

Public health relevance
PROJECT NARRATIVE Glioblastoma is an aggressive, fast-growing brain cancer that represents nearly half of all malignant brain tumors. Due to the high rate of recurrence, current treatment options only extend survival following initial diagnosis to one year. Building on years of basic research into the biology of glioblastoma identifying nonmuscle myosin II as a potential therapeutic target, an interdisciplinary team has been brought together with the necessary expertise in glioblastoma and myosin biology, drug development and the clinical treatment of glioblastoma to advance a small molecule inhibitor for glioblastoma therapy.